Develop AAV9 gene replacement therapy for treating MPS I

Project Summary
NeuroGT, Inc is a start-up company founded by Dr. Haiyan Fu, an associate professor in the Gene Therapy
Center at University of North Carolina at Chapel Hill, with the mission of develop and commercialize effective
gene therapy products to treat rare neurogenetic diseases in humans. The goal of this project is to develop an
effective gene therapy product targeting the root cause for treating
Mucopolysaccharidosis (MPS) I is a fatal lysosomal storage disease (LSD) caused by autosomal recessive
defects in α-L-iduronidase (IDUA). Severe form of MPS I (MPS IH, Hurler syndrome) represents the majority of
known cases, with premature deaths usually before age 10 years, predominantly due to neurological
deterioration and cardiorespiratory failure. No effective treatment is available for neurological indications of
MPS IH. Because of the global diffuse neuropathy and the blood brain barrier (BBB), MPS IH is not amenable
to either recombinant enzyme replacement therapy or bone marrow transplantation, which are the standard of
care for treating somatic symptoms of MPS I. Gene replacement therapy targeting the root cause has been
demonstrated to be an ideal strategy for treating monogenic diseases. Numerous studies have demonstrated
successful in IV or intrathecal (IT) delivery of trans-BBB-neurotropic AAV9 for treating neurogenetic diseases.
Importantly, the efficacy and safety profiles of IV and IT rAAV9 delivery have been demonstrated to be highly
reproducible across different neurogenetic diseases, including LSDs.
For optimal therapeutic potential, we have developed a novel self-complementary (sc) AAV vector, scAAV-
mCMV-∆hIDUAop, to deliver a miniaturized human IDUA cDNA with codon-optimization. When tested in vitro in
human MPS IH cells, this scAAV-∆hIDUAop vector construct was shown to express functional IDUA protein at a
level 8-fold higher, than the single-stranded (ss) rAAV-hIDUAop vector. Importantly, the transduction with
scAAV--∆hIDUAop vector also lead to 11-fold increase in the secretion of rIDUA, which can enter non-
transduce MPS I cells and clear GAG storage there. Our preliminary data strongly support the potential of
further development towards clinical application in humans. In this proposed project, for clinical relevance, we
will test this new scAAV-∆hIDUAop vector in MPS I mouse model using AAV9, via IV, intrathecal (IT) and IV+IT
delivery, to assess the therapeutic potential and determine the optimal regimen for treating MPS I. The
proposed project will allow us to generate rigorous preclinical efficacy and safety data, to support the
subsequent clinical development and commercialization.

Public health relevance
Project Narrative Gene therapy products using adeno-associated-virus (AAV) vector have shown great promise for treating monogenetic diseases in humans. This STTR project targets the unmet need for mucopolysaccharidosis (MPS) I, especially MPS IH (Hurler Syndrome), a devastating fatal disease in children. The goal of this STTR is to develop an effective gene replacement therapy product targeting the root cause for the treatment of MPS I in patients towards commercialization.